Optimizing a Mobile Health Platform for Sleep Promotion and Obesity Prevention in Children

SUMMARY/ABSTRACT
Shorter sleep duration has been consistently associated with childhood obesity, and the American Academy of
Pediatrics recommends that pediatricians promote sleep as part of their obesity prevention efforts. The pediatric
primary care setting has enormous potential to promote sleep, but a lack of time at the point of care is a key
barrier, and insufficient sleep and childhood obesity are not equally distributed across sociodemographic groups.
To overcome these barriers, mobile health platforms need to be developed to deliver behavioral sleep promotion
remotely in the home setting, with tailoring to individual and contextual factors to help ensure equitable
effectiveness across sociodemographic groups. Multi-component sleep promotion interventions have been
developed, and initial findings suggest that behavioral sleep interventions are effective. However, these
interventions have not been designed for remote delivery in the pediatric primary care context. Furthermore, the
individual components have not yet been optimized, meaning some components may be ineffective or counter-
effective. The study team’s objective is to engineer a mobile health platform for the pediatric care setting to
promote longer sleep duration for childhood obesity prevention. Their central hypothesis is that they will identify
an optimal set of intervention components to increase sleep duration and prevent excess weight gain, with
equitable effectiveness across sociodemographic backgrounds. This hypothesis will be tested by pursuing three
specific aims and will be guided by the Multiphase Optimization Strategy (MOST) framework. Under aim 1, an
optimization trial will be conducted using an innovative experimental design to determine optimal component
settings for sleep promotion. A total of four candidate components will be experimentally tested: 1) a sleep goal
component, 2) a digital messaging component, 3) a parent-directed incentive component, and 4) a personalized
feedback component. An advisory board (family, youth, and clinicians) will provide feedback throughout to
ensure acceptability of the component content. Under aim 2, the investigative team will determine if optimal
settings for sleep promotion lead to lesser gains in fat mass index. They will also measure total energy intake
and the timing and composition of meals to gain mechanistic insights. Under aim 3, the investigators will
determine if optimal settings for sleep promotion are comparable across individual- and neighborhood-level
sociodemographic factors. This innovative research shifts attention from the problem of insufficient sleep to a
solution for insufficient sleep, and represents the first application of the MOST framework to engineer a mobile
health platform to promote sleep for obesity prevention that will be equitable across sociodemographic groups.
The proposed research will greatly advance the field of behavioral sleep medicine and reimagine how insufficient
sleep duration and obesity are prevented in pediatric healthcare.

Public health relevance
NARRATIVE The proposed research is relevant to public health because the prevalence of insufficient sleep and obesity in childhood are excessively high. Pediatricians should promote sleep as part of obesity prevention efforts, but primary care providers currently lack the necessary tools to promote sleep. This project aims to engineer a mobile health platform for the pediatric care setting to promote sleep for obesity prevention and is relevant to the NICHD’s mission to enhance the lives of children and adolescents, and is especially relevant to a NICHD’s Child Development and Behavior Branch high-priority research area to support research on behavioral and health promotion interventions within pediatric primary care.